Adminstrative Core

The main purpose of this Core, which consists ofa half-time Project Coordinator, and a small operating budget, is to provide Dr. Sun, the Principal Investigator, adequate administrative support thus enabling him to coordinate, in a cost-effective manner, the research activities of this Program Project. This Core has worked extremely well during the last grant period (see section E on Past Performance).

Public health relevance
N/A